Targeting mitochondrial dynamics in drug-resistant acute myeloid leukemia

PROJECT SUMMARY/ABSTRACT
Acute myeloid leukemia (AML) is the second most common leukemia in adults and typically has a dismal
prognosis and high mortality, which is exemplified by a 28% five-year overall survival rate. Venetoclax, a selective
inhibitor of the anti-apoptotic protein BCL-2, has received FDA approval for the treatment of AML. Despite
promising early responses of AML patients to venetoclax, drug resistance ensues after prolonged treatment and
highlights the urgency for a deep understanding of the underlying mechanisms. Recently, I discovered that
mitochondria in AML cells undergo a morphological change upon venetoclax resistance. Using a genome-wide
CRISPRi screen in human AML, I identified genes involved in mitochondrial structure as synthetic lethal
vulnerabilities for venetoclax in AML. Mitochondria of venetoclax-resistant AML cells actively modify their
architecture and function to prevent apoptosis. Supporting this, OPA1, the master regulator of mitochondrial
cristae structure, and CLPB, a mitochondrial chaperonin, were strikingly upregulated in venetoclax-resistant AML
cells relative to the sensitive cells. CLPB directly interacts with OPA1 to maintain the physiological mitochondrial
morphology. Promisingly, genetic CLPB or OPA1 ablation enhances venetoclax-induced apoptosis of AML cells,
by promoting cristae remodeling and mitochondrial stress.
This proposal aims to leverage these observations by 1) delineating the mechanistic details by which
mitochondrial dynamics and homeostasis lead to acquisition of drug resistance in AML, using super-resolution
microscopy, electron tomography, and biochemical techniques, and 2) assessing the therapeutic potential of
perturbing mitochondrial structure to augment venetoclax action in preclinical AML mouse models. This research
stands to have significant clinical impact, because it can serve as a basis for developing new combinational
targeted therapies for patients with AML.
In addition, this proposal outlines my career development plan for obtaining the requisite training to transition
into a successful independent investigator. This includes 1) guidance from my esteemed mentor Dr. Iannis
Aifantis, expert in blood malignancies and mouse models; 2) scientific training by an expert advisory panel,
consisting of Drs. Raoul Tibes, Hans-Willem Snoeck, Kivanc Birsoy and Evripidis Gavathiotis, all in top institutes
of NYC; 3) hands-on training using state-of-art equipment, including super-resolution microscopy with Dr. Eli
Rothenberg; 4) collaboration with experts in microscopy and bioinformatics; and 5) career development courses
sponsored by NYU. The laboratory of Dr. Aifantis and NYU Department of Pathology will provide the resources
critical to my training and research, ensuring my success. This extensive professional growth program will guide
me during the mentored phase excelling as an independent academic scientist. Collectively, the proposed
research and career development plans are expected to generate data with significant impact on circumventing
targeted-therapy resistance in AML and setting the basis of my future research as an independent researcher.

Public health relevance
PROJECT NARRATIVE Mitochondria are dynamic organelles that actively change their shape to accommodate cellular requirements. Cancer cells can exploit this adaptation to support their energy demands or resist to drug-induced cell death. This proposal aims to 1) determine the precise molecular mechanisms cancer cells alter their mitochondrial morphology during acquisition of drug-resistance and 2) evaluate the therapeutic potential of combining small molecules targeting mitochondrial structure with cell death-inducing agents in acute myeloid leukemia.